Nucleation and Dissolution Mechanism Underlying ALS/FTLD-linked FUS Condensates

PROJECT SUMMARY
Fused in sarcoma (FUS) is an RNA binding protein which can readily undergo liquid-liquid phase separation
(LLPS) to perform its proper functions in the nucleus. Mutations in FUS and/or cellular stress lead to
mislocalization of FUS from the nucleus to the cytosol and aberrant LLPS, leading to the formation of toxic
aggregates that are more gel-like or solid-like than wild type (WT) FUS whose condensates have dynamic liquid-
like properties. Toxic aggregates of mutant FUS is a hallmark of age-dependent neurodegenerative diseases
such as amyotrophic lateral sclerosis (ALS) and frontotemporal lobar dementia (FTLD) which are characterized
by a progressive loss of motor neurons and eventual death in patients. I propose to identify mechanisms
underlying the formation of cytotoxic FUS aggregates which contribute to the death of motor neurons and disease
progression. Specifically, I propose to utilize single molecule techniques to investigate the nucleation and
dissolution mechanisms underlying FUS aggregation and the underlying interactions driving FUS LLPS which
become perturbed in disease-linked mutants. Aim 1 will quantify the oligomerization status of FUS in cells under
WT, stressed and mutant conditions using single molecule pulldown (SiMPull) analysis. This aim will test the
impact of multiple ALS/FTLD-linked FUS mutations multiple forms of stress on FUS oligomerization in a
localization-dependent manner. Aim 2 will utilize in vitro nucleation and dissolution assays to compare the
nucleation pattern of WT versus mutant FUS oligomers and will identify the mechanism of action underlying FUS
condensate assembly. In addition, aim 2 will test the interactions necessary to maintain FUS condensates using
dissolution assays with a panel of various dissolving agents that will perturb hydrophobic, electrostatic, and RNA
interactions, to investigate the effects of loss of respective interactions on FUS oligomers. Aim 3 will investigate
the role of FUS-RNA interactions in FUS nucleation by determining the RNA sequences, lengths, and structures
necessary for nucleating and maintaining FUS condensates, and will identify interactions that are disrupted in
ALS/FTLD-linked mutant FUS condensates. This proposal is strengthened by contributions from three
collaborators (see support letters), all of whom are experts on ALS, LLPS, or can provide technical support. The
activities planned under this award including collaborations, professional development opportunities, engaging
and participating in scientific conferences, mentoring undergraduates in the lab, and improving scientific
communication and critical thinking skills will allow me to successfully complete my PhD and prepare me for a
postdoctoral position and later, to attain a career in academia. This proposal will allow me to pursue my long-
term career goal and will utilize single molecule techniques to gain a better mechanistic understanding of
ALS/FTLD-linked FUS mutants to prevent disease progression.

Public health relevance
PROJECT NARRATIVE Fused in sarcoma (FUS) is a nuclear RNA binding protein (RBP) with many roles in RNA metabolism. Mutations in FUS mislocalize FUS to the cytosol and drive the formation of toxic aggregates, a hallmark of age-dependent neurodegenerative diseases such as amyotrophic lateral sclerosis (ALS) and frontotemporal lobar dementia (FTLD). The mechanism underlying formation of these toxic aggregates is unknown, therefore, we propose to apply single molecule techniques to investigate the formation and maintenance of FUS multivalent interactions that may elucidate the mechanism of FUS dysregulation in aberrant LLPS.